CCSG - Administrative Supplement - ETCTN EDDOP {Accruals} 2022

PROJECT SUMMARY
This application is being submitted in response to the PA-20-272.
This application supports participation of the University of Chicago Medicine Comprehensive Cancer Center
(UCCCC) in the Early Therapeutics-Clinical Trials Network (ETCTN) to provide access by NCI Cancer Centers
to agents under NCI development.
The UCCCC has been affiliated with the ETCTN since 1988, first through a Phase 1 U01 funding mechanism,
then under NCI contracts to perform Early Therapeutics Development with Phase 2 Emphasis and then
through an ETCTN UM1 grant that ended 3/1/16. Since 6/6/16, the UCCCC has continued its affiliation with the
ETCN through the EDDOP mechanism, having accrued 55 patients across 14 trials.
More broadly, the UCCCC maintains an active and robust early therapeutics clinical research program.
Specifically, in calendar year 2021, a total of 881 patients were accrued to therapeutic clinical trials, of which
584 were Phase 1, Phase 1/2 or Phase 2 trials across all the major disease areas. Notably, underrepresented
minorities constituted 22.5% of all accruals, 27% of early phase trials were investigator initiated, and of these,
19% were multi-institutional. The UCCCC and its investigators conform to all ETCTN processes and
procedures, including the use of the Central IRB, the OPEN registration system, Medidata Rave for data
management, and CTEP-AERS for adverse event reporting.

Public health relevance
PROJECT NARRATIVE Through its Experimental Therapeutics Clinical Trials Network (ETCTN), NCI creates a drug development plan that includes Phase 1 and Phase 2 studies, which are an essential part of the CTEP drug development process. The University of Chicago Medicine Comprehensive Cancer Center will contribute to the goals of the NCI through its investigators by providing access to disease-oriented as well molecular oriented early phase clinical trials, and expertise in conducting Phase 1 and 2 ETCTN studies.